Saf-T-Drape: Sterile Drapery Shielding for Radiological Scanners

Abstract: Saf-T-Drape: Sterile Drapery Shielding for Radiological Scanners
Current drapery solutions for MRI, CT, and PET scanners are inconvenient to install, prone to failure during use,
and can impede image-guided procedures. Our new Saf-T-Drape shielding will have an impact in 3 areas:
minimally invasive image-guided surgery; mitigation of Hospital Acquired Infection (HAI), and increased
efficiency for diagnostic radiology. To date, the number of procedures requiring a sterile field in the scanner has
been relatively small, and practitioners have largely overlooked the inconvenience. However, the number of
image-guided neurosurgical procedures is growing, and improved drapery is one of several improvements that
could significantly reduce the barriers for more widespread adoption. Furthermore, Hospital Acquired Infection
(HAI) is a large and growing problem. About one in 31 hospitalized patients has at least one HAI, with rates up
significantly since 2020, according to the CDC, which reports direct medical costs of HAIs >$28.4B annually.
Recent large increases in rates for Candida auris and Clostridioides difficile highlight the need for mitigating
surface-based infection sources. HAI have profound implications for affected patients, as well as adversely
affecting hospitals’ financial and reputational standing. A 2017 study found that 4% of patients passing through
an Emergency Room CT scanner contracted a HAI associated with that scanner. The International Society for
Infectious Disease recommends use of a disposable plastic barrier changed between each patient as a best
practice for preventing infectious in the radiology department. No commercially available drapery product makes
implementing this practice feasible. Scanner cleaning following a highly infectious patient takes 20-30 minutes,
but total down time can be much longer, since facilities frequently wait for 30-120 minutes for the specially trained
cleaning team. Since MRI and CT scanners typically generate $3k-$6k per hour, even a 15 minute interruption
can be very expensive. Simple measures to greatly reduce or eliminate scanner downtime can be extremely
cost-effective. Scanner down-time translates directly into lost revenue, and the absence of an important
diagnostic tool. Saf-T-Drape was created in response to a neurosurgeon’s complaints about the ad-hoc nature
of current drapery solutions, which included the difficulty and time to install, frequent sagging enough to interfere
with visibility and equipment, and easily becoming dislodged, especially by larger patients. We conceived the
Saf-T-Drape concept of a semi-rigid liner for the scanner bore that is easily installed, easily disposed, economical
for single-patient use, robust against patient movement, and does not interfere with procedures. A patent has
been applied for Saf-T-Drape’s novel fastening mechanism, which does not interfere with the scanner bed
movement. We propose several straight-forward measurements to characterize Saf-T-Drape, which will assure
potential collaborators and investors that it is safe, it does not degrade image quality, it is compatible with current
MRI and CT scanners, and is likely to be effective in mitigating transmission of infectious diseases.

Public health relevance
Current drapery solutions for MRI, CT, and PET scanners are inconvenient to install, prone to failure during use, and can impede image-guided procedures. An important application for drapery for radiological scanners is Emergency Room- based scanners, which can become soiled and unusable for 1-2 hours. Finally, with a recent rise in Hospital-Acquired Infection (HAI), the International Society for Infectious Disease recommends use of a disposable plastic barrier changed between each patient as a best practice for preventing infectious in the radiology department. Our product, Saf-T-Drape, is a semi-rigid liner for the scanner bore that is easily installed, easily disposed, economical for single-patient use, robust against patient movement, and does not interfere with procedures. We propose designing and building prototypes, and testing them in realistic clinical environments. We will examine the effect on image quality for MRI and CT images, we will test the ability of Saf-T-Drape to mitigate scanner-patient cross infection, and we will examine usability and durability factors. The goal is to characterize Saf-T-Drape with regard to image quality, patient safety aspects, and mitigation of disease transmission, so our clinical colleagues can justify requesting approvals to test Saf-T-Drape in a realistic clinical environment.